Real-time mapping and adaptive testing for neural population hypotheses

ABSTRACT
Recent advances in neural recording technologies have made it possible to study increasingly large and di-
verse subsets of neurons, producing a growing interest in the collective computational properties of neural pop-
ulations. Ideally, causally testing these population hypotheses requires timing and selecting experimental ma-
nipulations based on the current state of neural dynamics, but technical limitations have rendered this difﬁcult in
practice. However, recent work on real-time preprocessing and modeling of neural data has demonstrated that
up-to-the minute estimates of neural population dynamics are indeed possible, opening the door to adap-tive
experiments in which the design of the task changes based on incoming data. The goal of this proposal is to
disseminate these advances to the widest possible audience of systems neuroscientists by: 1) Designing and
validating new methods for mapping neural states and behavior online. 2) Developing algorithms for optimally
timing and selecting experimental manipulations based on these instantaneous neural and behavioral states. 3)
Making improv, our platform for adaptive experiments, easier to install, use, and conﬁgure for diverse model
organisms and hardware setups. By allowing researchers to test ideas online, such tools will facilitate rapid
“drill-down” from the whole brain to the local circuit levels, maximizing statistical efﬁciency in limited experi-
mental time and providing stronger causal inferences for neural population hypotheses, with broad implications
for systems neuroscience.
1

Public health relevance
PROJECT NARRATIVE- From Parent Grant The purpose of this project is to design new methods for testing hypotheses about how groups of neurons function together. Our goal is to build algorithms and software that will enable experiments to adapt in real time as new data arrive, reﬁning hypotheses based on up-to-the minute analysis. These tools will enable us to both explore complex data interactively and to perform more powerful experiments that give insights into how dynamical brain activity produces behavior. 2